Evaluating Health Services for Justice-Involved Veterans to Improve Policy and Practice

Background: An estimated 181,500 veterans are incarcerated in prison or jail with thousands more arrested,
involved in courts, or on probation or parole each year. These “justice-involved Veterans” have extensive
medical and mental health disorders, housing instability, and an elevated risk for suicide and other mortality.
Since 2007, the Veterans Health Administration (VHA) has operated the Veterans Justice Programs (VJP) to
provide outreach, assessment, and case management for justice-involved Veterans in local courts, jails, and
prisons, and to liaise with criminal justice partners. In fiscal year 2018, VJP provided services to 80,653
Veterans. Research on the link between VJP services and Veteran outcomes is hindered by a lack of
systematic methods to assess VJP structures, processes and outcomes. VJP and Veteran-focused criminal
justice initiatives continue to implement new features without the tools needed to measure, describe, and
evaluate their components. To inform program planning and resource allocation, it is essential to know which
structures and processes are linked to better outcomes for justice-involved Veterans. This explanatory
sequential mixed methods study will develop a VJP program evaluation dashboard to determine gaps in VJP
and VHA services for justice-involved Veterans. By using this dashboard, VJP leaders can develop policies
and practices to improve healthcare, housing and mortality outcomes among justice-involved Veterans.
Significance/Impact: Given the elevated risk mental health disorders, homelessness, and mortality for justice-
involved Veterans, it is imperative that VHA provides services to address the needs of this population. This
study responds to VA priorities to deliver effective and efficient care to Veterans, Veterans Treatment Court
legislation, the Office of Research & Development priority to increase real-world impact of research, HSR&D
priorities of mental health treatment and health equity, and the VJP priority to maximize successful outcomes
among justice-involved Veterans.
Innovation: VJP is at the forefront of partnering with non-VHA criminal justice and community agencies to
serve justice-involved Veterans. This project breaks new ground by examining the full continuum of VJP/non-
VHA partnerships and drawing lessons that can be applied to Veterans who receive services outside VHA.
Specific Aims: The three aims are scientifically important and reflect extensive input from justice-involved
Veterans and VJP leaders and staff: (1) Identify Veteran, VJP, VHA facility, and criminal justice factors that
predict healthcare, housing and homeless services, and mortality outcomes for justice-involved Veterans; (2)
Qualitatively evaluate Veterans’ and other key stakeholders’ perspectives of factors that explain successful
healthcare, housing, and mortality outcomes among justice-involved Veterans; and (3) Develop a program
evaluation dashboard of VJP services, VHA resources, and criminal justice factors that impact justice-involved
Veteran outcomes.
Methodology: The current study is guided by Behavioral Model for Vulnerable Populations. In Aim 1, we will
conduct multi-level regression models with a random effect for facility, to examine Veterans, VJP, VHA facility,
and criminal justice factors associated with successful outcomes among justice-involved Veterans (n=80,653 in
FY18). For Aim 2, we will conduct qualitative interview with 32 justice-involved Veterans and 48 VHA and
criminal justice staff at 8 VHA facilities and partner agencies (n=80). Aim 3 will be to develop and pilot-test
(n=14) a program evaluation dashboard to identify service gaps and inform policy and practice.
Implementation/Next Steps: Results will be of immediate value to VJP, the National Center on
Homelessness Among Veterans, and VHA to prioritize and tailor health services to justice-involved Veterans to
maximize benefit and used to develop interventions to improve the health and healthcare of justice-involved
Veterans that will be evaluated in a subsequent IIR.

Public health relevance
Veterans involved in the criminal justice system have complex mental health and medical treatment needs, unstable housing, and an elevated risk for suicide and other mortality. The Veterans Justice Programs serve more than 80,000 Veterans per year but lack systematic methods to prioritize and tailor resources to improve outcomes among justice-involved Veterans. The proposed project aims to identify Veteran, Veterans Justice Programs, Veterans Health Administration, and criminal justice factors associated with successful Veteran outcomes and develop a program evaluation dashboard using perspectives from Veterans and other key stakeholders to contextualize findings. The goal of this research is to produce knowledge and a dashboard the Veterans Justice Programs can use to improve the effectiveness and efficiency of health services delivered to justice-involved Veterans and ultimately improve the health and mortality risk of this population.